ADMIN CORE

Administrative Core Abstract The Administrative Core for this Program Project grant will serve the Project leaders by facilitating interactions and guaranteeing that all administrative functions, including financial reports, compliance with regulations, and communication with the NIH, are executed correctly and expeditiously. The Grant Administrator will work closely with the Principal Investigator to ensure smooth operations and to conserve resource for the scientific projects. The Administrative responsibilities within the Program are kept at a very modest level as the Project leaders interact frequently and there are no Scientific Cores within the Program. The Administrator will organize at least yearly meetings with the External Advisory Committee, either by videoconference or in person.

Public health relevance
N/A